Characterizing the Functional Architecture of the Necklace Olfactory System

Abstract A central goal of modern neurobiology is to understand the neural mechanisms that transform sensory inputs from the outside world into appropriate and adaptive behavioral outputs. Here we propose to approach this general problem by answering key questions regarding the organization and function of the olfactory system, the main sensory modality used by most animals to interrogate the environment. In mammals, the challenge of odor detection is addressed by multiple olfactory subsystems that each convey information about a unique subset of odor space. In the two largest olfactory subsystems — the main and the vomeronasal systems — sensory neurons detect odors through g-protein coupled receptors (GPCRs) expressed in a characteristic one-receptor-per-neuron pattern; odor information is then organized into channels called glomeruli in the olfactory bulb, and is relayed to higher brain centers responsible for odor processing and behavior. However, not all olfactory subsystems follow this pattern: the mysterious olfactory “necklace” is comprised of sensory neurons that innervate a string of glomeruli in the olfactory bulb, and which express the single-pass transmembrane receptor guanylate cyclase-D (GC-D) rather than GPCRs. GC-D detects chemical cues, including urinary peptides and carbon disulfide, that act as unconditioned stimuli during a specific form of odor learning, the social transmission of food preferences (STFP). We have recently identified a new family of 4 transmembrane-containing odor receptors called the Membrane Spanning 4As (MS4As), which are co- expressed in necklace sensory neurons, and which detect odors ranging from food scents to pheromones. This co-expression of non-GPCR odor receptors in necklace sensory neurons suggests that the necklace system plays a fundamentally different role in olfactory perception from the discriminative functions for which the main and vomeronasal systems appear to be optimized. Here we will take advantage of new genetic tools we have established, and novel neural tracing and behavioral techniques we have developed, to tease apart the unique function of the necklace system in odor perception and behavior. We will first assess necklace sensory responses in mice in which single Ms4a receptor genes are mutated or the entire Ms4a gene cluster is deleted, and also ask whether MS4A and GC-D ligands, when presented simultaneously, activate necklace sensory neurons synergistically, additively or in some other pattern (Aim I). We will then perform anterograde and retrograde tracing (including cell type-specific trans-synaptic tracing) to identify brain areas and cell types that receive information from the necklace system (Aim II). Finally, we will use genetics and optogenetics to manipulate the necklace system, thereby establishing the roles of MS4A ligands, receptors and projections from the necklace glomeruli to the brain in STFP-based odor learning. These experiments will lead to important discoveries about the functional architecture of a behaviorally relevant neural circuit, and will establish an important platform for testing future hypotheses about the mechanisms that couple sensation to action.

Public health relevance
Project Narrative We have recently discovered a new mechanism through which mammals detect smells. Here we propose to leverage this discovery to better understand how the nose organizes information about scents, how this information is sent to the brain, and how specific brain regions that receive this information might be important for odor-based learning. This work will lead to insights into how neural circuits influence brain function, thereby improving our understanding of neural physiology and offering a window into how pathological damage might alter information processing and behavior.